Mechanoregulation of Basal Keratinocyte Migration in Wounded Tissue

Project Summary
Epithelial homeostasis is maintained by the balance of mechanical forces acting upon cells across the tissue-
scale. Injury disrupts this mechanical balance and it is unclear how changing homeostatic mechanical signals
impacts cell behavior needed for wound repair. Failure to efficiently repair can lead to fibrotic scarring, chronic
non-healing wounds, and contribute to pathology. Epithelial wound repair relies on the migration of basal
keratinocytes to the site of damage. While it is known that basal keratinocytes are sensitive to mechanical forces,
we lack an understanding of how epithelial injury alters tissue mechanics in vivo and how these wound-induced
biophysical changes subsequently coordinate basal keratinocyte behavior needed for wound repair. This study
aims to address these issues by using larval zebrafish, which are amenable to real-time, intravital imaging due
to their optical transparency. Preliminary live-imaging experiments show that epithelial injury causes rapid basal
keratinocyte migration to the wound site, which is needed for efficient repair. Basal keratinocyte migration is
dependent on mechanical signals, such as membrane tension due to cell swelling, and is associated with a
transient and localized disruption of epithelial tissue architecture at the wound edge. Basal keratinocyte migration
can be inhibited by blocking Arp2/3 complex activation or through Talin1 knockdown, suggesting a potential link
between mechanical signaling and F-actin or focal adhesion complex remodeling in vivo. Further, transiently
weakening cell adhesion to the extracellular matrix alters basal keratinocyte migration, causing poor wound
healing, and resulting in chronic disruption of epithelial architecture. This phenotype mimics pathology associated
with Kindler Syndrome, a skin disease in which patients show wound healing defects in response to injury. These
preliminary observations demonstrate that basal keratinocytes of larval zebrafish respond to mechanical signals
in epithelial tissue after injury by initiating a migratory response that is required for efficient wound healing. They
also suggest that defective basal keratinocyte migration may contribute to wound healing pathology. The
proposed study will investigate how tension sensing by the mechanotransducers Piezo1 and Talin1 regulate
wound-induced basal keratinocyte behavior by F-actin and focal adhesion remodeling, respectively. These
findings will subsequently be translated to investigate a zebrafish model of Kindler Syndrome to determine the
contribution of dysregulated basal keratinocyte behavior to wound healing pathophysiology. To ensure the
success of this project, a tailored training plan has been developed that takes advantage of the excellent research
environment at the University of Wisconsin – Madison. Dedicated training in the use of the zebrafish model
organism for wound healing studies and advanced in vivo imaging techniques for quantifying epithelial tissue
mechanics will aid in the completion of the stated aims. This training will facilitate a successful transition to
research independence.

Public health relevance
Project Narrative Failure to efficiently heal from epithelial damage can result in fibrotic scarring, chronic wounds, and contribute to numerous skin diseases. Migration of epithelial cells represents a critical aspect of the wound healing response, but our understanding of how epithelial cells detect injury and initiate a migratory response is limited. This study aims to investigate how injury-induced mechanical signaling regulates epithelial cell behavior and determine how defects in this process contribute to pathology.